Comprehensive tools and models for addressing exposure to mixtures during environmental emergency-related contamination events

Overall Program Description
Man-made and extreme weather event-related disasters coupled with economic activity and the
enhanced vulnerability of communities located in close proximity to potential sources of hazardous chemicals markedly increase risks from catastrophic chemical contamination events. The complexities of chemical exposures and their potential adverse health impacts, the need to rapidly and comprehensively evaluate the potential hazards of exposures to complex mixtures, and the necessity of protecting susceptible populations and life-stages call for novel approaches in the Superfund Research Program. This Center consists of a team of well-established scientists from biomedical, geosciences, data science, and engineering disciplines who share a common goal: to develop, apply, and translate a comprehensive set of tools and models that will aid first responders, impacted communities, and government agencies in characterizing and mitigating the human health consequences of exposure to hazardous mixtures. These will be applicable for both existing contaminated waste sites and disaster-related contamination events. Project 1 will develop novel analytical and computational strategies for exposure assessment of complex mixtures. Project 2 will develop novel tools to rapidly characterize pediatric respiratory health risks from exposure to hazardous volatile organic compounds after environmental disasters. Project 3 will develop and use feto-maternal interface tissue chip models for rapid assessment of preterm birth risks of hazardous substances. Project 4 will continue development of predictive in vitro methods for quantitative evaluation of the complex mixtures and intra- and inter-individual variability in toxicity. Project 5 is responsive to the Superfund remediation mandate by using experimental and computational engineering to develop optimized multi-component sorbents for toxic mixtures. A Disaster Research Response (DR2) Core will be a centralized resource for environmental sampling and assessment before, during, and after disasters. A Data Management and Analysis Core will develop computational and statistical tools for analysis and integration of “big data” in environmental health. A Risk and Geospatial Science Core will provide the Center with data and services for characterizing human health risks and the geographic distribution of hazardous substances during disasters. The Center will engage with community organizations and public health practitioners in Texas to address health concerns of the populations that may be impacted by environmental emergency-related contamination events. We will continue training students and postdoctoral fellows in inter-disciplinary approaches across our scientific areas, decision making and emergency response. The research translation to local, state, national and international stakeholders involves both technology transfer and regular outreach. Finally, the management of this program includes close partnerships with the Texas A&M University administration and the NIEHS-funded Center for Translational Environmental Health Research, and is overseen by the advisors representing academia, federal and state agencies, industry and a non-governmental organization.

Public health relevance
This Center is focused on developing better, faster, more informative research tools and computational models that aid during response to and recovery from environmental emergencies. Extreme weather events, human economic activity, and close proximity of human dwellings to sites of intense industrial activity together increase vulnerability to disasters that may involve exposure to hazardous chemicals. We bring together a team of scientists from biomedical, geosciences, data science and engineering disciplines to propose solutions for characterization and management of both existing and environmental emergency-created hazardous waste sites in both coastal and inland regions.